Center for Clinical and Translational Science

Contact PD/PI: Kimberly, Robert P.
ABSTRACT − OVERALL. The vision of the Center for Clinical and Translational Science (CCTS) is to reduce
health disparities in diseases disproportionately represented within the Deep South as we accelerate discovery
to improve human health. We have established a robust Partner Network – spanning Alabama, Mississippi
and Louisiana – to ensure that our research and training efforts serve the special populations in our region
while maximizing collaborative synergies in translational research to advance fundamental and clinical
discovery through to application to human health and healthcare delivery. The CCTS will further the
development of a vibrant, diverse clinical and translational research workforce (Aim 1) by providing education
and training programs for learners at all career stages in support of innovative, multidisciplinary, engaged team
research. We will continue to create and apply novel approaches in gamification, experiential learning,
mentoring, and team-focused design thinking in I-Corps™ to convey new skills, perspectives and understanding
of the translation process. We will catalyze collaborative, coordinated data analytics and informatics across the
Partner Network and the CTSA consortium (Aim 2) by extending the digitally integrated ecosystem enabling
full utilization of high dimensional data together with rich, deep clinical information to enable discovery research
from the bench to the learning healthcare system. In keeping with our goal of reducing regional health
disparities, we will expand the involvement of our communities in trusting, productive relationships and broadly
engaged teams that advance knowledge to impactful implementation (Aim 3). We will work closely with local
constituencies to address health issues of particular significance to our region and will share best practices in
pursuit of community engaged studies to enhance culturally sensitive participation, safety, confidentiality and
effectiveness. Toward the rapid and efficient translation of rigorously designed and effectively implemented
clinical studies and trials (Aim 4), the CCTS Partner Network will support the ethical conduct of scientifically
rigorous pilot and clinical research by providing a range of specialized services, resources and consultations.
This effort will develop and will leverage innovative processes established by the CTSA Consortium and will
promote the use of collaborative tools and processes that enable the rapid and efficient execution of multi-site
clinical trials, taking advantage of the electronic health record to inform feasibility and access to study
populations. Finally, we understand the importance of evaluating the CCTS activities to assure efficiency,
quality and sustainability (Aim 5). We will use quantitative and qualitative assessment and feedback to assure
that training and research programs meet the needs of its scientific constituencies and the goals of the CCTS,
consistent with consortium-wide Common Metrics and Results Based Accountability evaluation activities. By
achieving these aims, the CCTS Partner Network will accelerate clinical and translational research in the Deep
South and advance the amelioration the significant health disparities faced by our populations.
Page 459
Project Summary/Abstract
Contact PD/PI: Kimberly, Robert P.

Public health relevance
PROJECT NARRATIVE. The Center for Clinical and Translational Science (CCTS) and its regional Partner Network of eleven institutions and four affiliates in the Deep South are dedicated to lessening health disparities and the disproportionate burden of disease in our population. We will accomplish these goals by supporting impactful translational research, pursuing novel team science-driven investigation into new therapies and health care delivery paradigms, and developing the next generation of a diverse, highly-trained clinical and translational research workforce to tackle health challenges. Our work will complement and inform national and international translational research efforts to improve public health and well-being.